Understanding the Role of Ulp1 as a clock for heterochromatin repair

PROJECT SUMMARY/ABSTRACT:
Maintenance of DNA integrity and information is essential for cell viability and genome stability. Various
extrinsic and intrinsic sources of DNA damage induce an especially detrimental form of lesion to chromosomes
known as double-strand breaks (DSBs). Repairing these breaks in pericentromeric heterochromatin is uniquely
challenging. Heterochromatin is mostly composed of repeated DNA sequences, and the availability of up to
millions of potential donor sequences associated with different chromosomes can trigger abnormal
recombination during homologous recombination (HR) repair. Some of the most important components
required for heterochromatin repair are commonly deregulated in cancer and other genome instability
disorders, suggesting heterochromatin repair defects as major contributors for these diseases. Understanding
the molecular mechanisms of heterochromatin repair and genome stability is essential for understanding how
environmental exposure to DNA damaging agents induce cancer and why individual sensitivity varies. We will
work with the D. melanogaster cell line model system, where the organization of heterochromatin in a distinct
domain and established approaches greatly facilitate the study of the molecular mechanisms involved. We will
also extend our studies to mouse and human cells, to establish conserved pathways. We previously identified
a unique pathway enabling ‘safe’ HR repair of heterochromatic DSBs, where repair starts inside the
heterochromatin domain, but it continues only after relocalization of repair sites to the nuclear periphery. A
critical regulator of this pathway is the SUMO protease Ulp1, which is required for restarting repair at the
nuclear periphery through unknown targets. We propose to gain insights into this function, by: i) establishing
the importance of Ulp1 compartmentalization to the nuclear periphery in the spatial and temporal regulation of
heterochromatin repair; ii) identifying functional Ulp1 partners responsible for HR restart at the nuclear
periphery; and iii) identifying Ulp1 targets for heterochromatin repair. This work will provide a deeper
understanding of the fundamental mechanisms protecting repeated DNAs from massive aberrant
recombination and chromosomal rearrangements and illuminate a missing link between HR progression and
the stability of repeated DNA sequences. I expect this research will provide a better understanding of the
mechanisms through which environmental exposures result in genomic instability and cancer, and to enable
the development of better strategies for prevention and treatment.

Public health relevance
PROJECT NARRATIVE: Cells are constantly exposed to DNA damage through internal and external sources which could cause especially detrimental double-strand breaks (DSBs) to form. In the proposed studies, we aim to understand how cells repair DSBs within regions in the chromosome named heterochromatin, which are mostly composed of repeated DNA sequences and are prone to generating genome rearrangements if misrepaired. Using the fruit fly, Drosophila melanogaster, and mammalian cell lines, we will establish how Ulp1, a protein we observed to be vital for timing repair progression, contributes to DSB repair, and how the absence of this protein can lead to genomic instability in the presence of environmental threats, contributing to tumorigenesis.